Role of TERRA in Telomere Maintenance and Telomere Stress Response

Project Summary
Human telomeres are specialized chromatin structures uniquely programmed to coordinate cellular division with
genomic integrity, thus providing a senescence barrier to cancer-cell evolution. Telomere structural maintenance
and genome sensing functions require extensive epigenetic signaling and higher-order chromatin dynamics that
are poorly understood. Our previous studies have revealed the important roles of telomere encoded repeat RNA
(TERRA) in the coordinate regulation of telomere chromatin structure, DNA replication and repeat-length
maintenance. We have found that TERRA expression can be regulated by subtelomeric binding of chromatin
organizing factor CTCF and tumor suppressor protein p53 in response to DNA damage stress. TERRA is also
regulated by histone assembly factors DAXX and ATRX that are implicated in the Alternative Lengthening of
Telomeres (ALT) through recombination. New preliminary data indicates that DAXX and ATRX are also required
for p53 binding to subtelomeres in response to DNA damage, suggesting a coordinate regulation of these factors
in telomere chromatin control and TERRA expression. In Aim 1, we investigate the role of DAXX and ATRX in
regulating telomeric and subtelomeric chromatin accessibility that is critical for p53 binding, TERRA expression,
and telomere DNA repeat stability. TERRA is also known to interact with shelterin component TRF2. In Aim 2,
we propose to investigate the interaction of TERRA with the TRF2 amino terminal GAR domain, and how this
further regulates telomeric DNA replication, chromatin structure, and chromosome conformation. Finally, in Aim
3, we will investigate how TERRA and telomeric chromatin can be processed into vesicular bodies in response
to telomeric stress to generate extracellular inflammatory signals. We propose that exosomal TERRA and
telomeric chromatin serve as telomere-specific Alarmins that are important in cellular senescence and tumor
microenvironment signaling. These studies will provide an integrated analysis of telomere transcription and
chromatin regulation, with stress response pathways that are important in human cancer and related
inflammatory disease.
Central Hypothesis: Telomeres are specialized epigenetic elements that sense and signal replication stress to
control cell proliferative capacity and senescence. TERRA represents an important telomere-repeat generated
molecule that functions in chromatin structure, DNA replication and repair, and DNA damage signaling.
Characterization of normal and pathogenic functions of TERRA will provide important insight into the
mechanisms driving genetic instability in cancer and related genetic instability syndromes.

Public health relevance
Project Narrative Telomere dysfunction is a hallmark of human cancer. Telomere-repeats containing RNA (TERRA) is a key regulatory molecule of telomere homeostasis, providing a mechanism for telomere chromatin remodeling, DNA replication processivity, and homologous recombination repair. TERRA may also serve as a telomere damage stress response signal that can alarm immune cell inflammatory signaling. Investigation of TERRA will provide information on telomere maintenance in cancer and aging, and may provide new methods for early stage cancer diagnosis.